National Epidemiologic Survey on Alcohol and Related Conditions-III (NESARC-III) DNA Storage

The National Epidemiologic Survey on Alcohol and Related Conditions-III (NESARC-III) was sponsored, designed and directed by the National Institute on Alcohol Abuse and Alcoholism (NIAAA). The NESARC-III is cross-sectional, based on a nationally representative sample of the civilian noninstitutionalized population of the United States aged 18 years and older. Utilizing the Alcohol Use Disorder and Associated Disabilities Interview Schedule (AUDADIS-5), the NESARC-III collected information on alcohol and other substance use, associated use disorders, related risk factors, and associated physical and mental disabilities. In addition, DNA was obtained through saliva samples from many of the survey respondents. The purpose of the current contract is continued DNA storage to facilitate whole genome sequencing and potentially more advanced sequencing in the future.